MANAGEMENT OF HEMOSIDEROSIS IN THALASSEMIA MAJOR

Endocrine, metabolic and cardiac complications in thalassemia are being studied along with the effect of current therapy of thalassemia on iron burden. (This is an ongoing study.)